Myosin-XIX and the molecular mechanism of actin-based mitochondrial organization

The long-term goal of this research project is to understand the enzymatic properties, motor properties, and cellular functions of myosin XIX (MYO19), a molecular motor protein involved in the transport and localization of mitochondria, an organelle central to multiple cellular processes. Mitochondrial dynamics have been shown to be partially actin-based, and mutations in other genes involved in mitochondrial dynamics lead to human diseases. Additionally, microarray analyses indicate that MYO19 expression is increased in certain cancers, compared to normal tissues. Previous studies show that MYO19 plays a role in mitochondrial motility in cultured cells as expression of GFP-tagged MYO19 constructs alters mitochondrial dynamics in a pulmonary cancer cell line and in a cultured neuronal cell line. Additionally, MYO19 depletion leads to defects in mitochondrial distribution during cell division. Taken together, analysis of the MYO19 protein sequence and biochemistry paired with analysis of the effect of altered MYO19 expression in cultured cells leads to the hypothesis that MYO19 plays a central role in mitochondrial dynamics, as it contains a conserved myosin motor domain and interacts with mitochondria via its tail domain. We will use both Myo19 knock-down and overexpression of functional and non-functional Myo19 constructs in cell culture models to determine what role Myo19 may play in a number of processes where mitochondria play a central role. Expression and purification of MYO19 motor domain will allow for a complete in vitro analysis of the rate and equilibrium constants associated with the motor properties of MYO19, and the contributions of class-specific sequence differences to those properties. Examination of both the enzymatic and motor characteristics of MYO19 in vitro will allow the determination of the mechanism by which MYO19 motor activity generates force, and determination of factors that may regulate its function in vivo. By examining the functional roles, enzymatic properties, and motor properties of MYO19 the proposed studies will further our understanding of mitochondrial dynamics in health and disease.

Public health relevance
Project Narrative Mitochondria play critical roles in healthy cellular function, most importantly the production of energy inside the cell. These “powerhouses” must be able to move to locations within the cell where energy needs are high, and alterations in these transport mechanisms have been associated with human disease. Myosin XIX is a motor protein involved in mitochondrial transport, and studying its motor properties will aid in understanding the mitochondrial transport in both human health and disease.